NIH SciEd Conference

To build and diversify a workforce that meets the nation’s biomedical, behavioral and clinical research
needs, the NIH invests in projects that provide science and health-related educational activities at the
precollege level. These projects focus on students and teachers at the pre-kindergarten to grade 12 (P-12)
level—as well as their families—who come from underserved communities.
The annual NIH SciEd Conference brings together individuals involved in these health and biomedical
science-focused P-12 Science, Technology, Engineering and Math (STEM) projects. This conference, which
originally was the PI meeting for the Science Education Partnership Award (SEPA) program, has been held
annually since 1991. In 2012, the conference expanded to include awardees and staff from all NIH-funded P-
12 STEM programs. Each year 200-250 individuals participate in the conference, including PIs and Co-PIs,
project staff and evaluators, P-12 teachers who participate in projects, NIH staff, and representatives of
other federal agencies involved in P-12 STEM education, including ED, NASA, NOAA and NSF. The
annual NIH SciEd Conference is the only federally-funded P-12 STEM meeting that includes all of the key
STEM agency programs. It thus plays an important role in interagency communication and building synergistic
interactions among projects funded by different agencies.
The goal of each 2.5-day NIH SciEd conference is to provide a forum for learning, sharing, dialogue, and
networking among conference participants. This is accomplished via plenary, breakout, poster, and networking
sessions. The outcomes of the conferences include higher quality projects and project evaluations, a reduced
incidence of projects “reinventing the wheel,” and the development of collaborations between NIH-funded
projects as well as synergistic interactions with P-12 projects and programs funded by the other federal STEM
agencies. Specific Aims for the NIH SciEd Conference are:
SPECIFIC AIM 1: Provide updates on trends, issues and challenges in P-12 STEM and ISE education
that are relevant to NIH awardees.
SPECIFIC AIM 2: Inform and educate the NIH P-12 STEM community about rigorous evaluation
methods and instruments.
SPECIFIC AIM 3: Provide opportunities for awardees to share information, best practices and
challenges; provide mentoring for new projects; and support the formation of collaborations.
The conferences will be held in the Washington, DC area. They are planned by an Organizing Committee
of NIH SciEd PIs and staff, which changes each year. An annual conference report is disseminated to
participants, federal P-12 STEM staff, and senior NIH officials. The conferences will be organized by a
University of Utah grantee team that has planned and hosted the NIH SciEd conferences since 2008.

Public health relevance
The NIH supports projects that educate pre-college students, teachers and the public about NIH clinical and basic research, building public understanding of and support for this research. These pre-college/public projects also play an important role in developing the biomedical research workforce, providing opportunities for students to engage in research and envision a biomedical career. The annual NIH SciEd conference enhances each project’s work through sharing of best practices and lessons learned, interactions with NIH staff, networking, and developing cross-project collaborations.